Developing Novel Chemo-optogenetic Tools for in Vivo Applications

Project Summary/Abstract
Optogenetics and chemo-optogenetics are powerful tools for modulating cell activities with light. These tools
accelerate neuroscience research by providing the necessary means for interrogating neural circuit function.
Clinical trials of optogenetic therapy for retinal diseases are already underway. Some of the limitations of these
current tools include a generally small light-induced current, their limited ability to manipulate specific cell
activity in deep tissue, the need for robust transgene expression to illicit physiological effects, and safety
concerns over long-term exogenous transgene expression. The novel chemo-optogenetic tools I develop will
address many of these issues. I previously developed a novel chemo-optogenetic tool based on the high
conductance TRPA1 channel which is suitable for modulating both neuronal and non-neuronal cell activity in
vivo. I have also developed and performed a small molecule screen based on the zebrafish light-induced
motion response and discovered molecular photoswitches that target endogenous vertebrate proteins. I am
characterizing two hits identified from this screen (Aim 1, K99 phase). One is a step-function chemo-
optogenetic system based on the TRPA1 channel. This new system will allow for light-controlled channel
ON/OFF, further enhancing TRPA1 utility. The second is a chemo-optogenetic system based on the TRPV1
channel. The next phase of my chemo-optogenetic tool-development program is to enhance TRPA1 channel
selectivity for sodium while preserving its high channel conductance (Aim 2, K99/R00 phase). This will provide
a more physiologically relevant light-induced generation of action potentials. I will also extend the zebrafish
light-induced motion response screening assay to specifically identify endogenous protein-targeting molecular
photoswitches with spectra in the near infrared range (Aim 3, R00 phase). The use of near infrared light allows
for deeper penetration into tissues and for compatibility with existing optogenetic tools and biosensor imaging.
Overall, my proposed research will generate novel chemo-optogenetic tools with improvements to unitary
channel conductance, light-controlled ON/OFF activity in deeper tissue, and require no or low levels of
exogenous gene expression. My research will also create a platform for the discovery of novel chemo-
optogenetic actuators that mimic natural cell activity. The next generation tools I develop will enhance our
ability to dissect biological processes such as the complex neuronal network of the brain and accelerate the
potential clinical use of optogenetics. My diverse team of mentors, advisors and collaborators have been
chosen to both ensure my success and to further my training in the relevant areas associated with this project
such as ion channel biology, chemical biology, electrophysiology, optogenetics and neuroscience. My training
plan will equip me with technical skills and knowledge for developing novel chemo-optogenetic actuators for in
vivo neuroscience applications and beyond, and provide a foundation for a successful transition into an
independent researcher.

Public health relevance
Project Narrative My proposed research will develop novel chemo-optogenetic tools suitable for in vivo applications. I will use in vivo zebrafish embryo screening, photoactivable small molecule modification, and ion channel engineering to discover and optimize chemo-optogenetic actuators. The tools I developed will accelerate potential clinical applications since little or no exogenous gene expression will be needed for sufficient small molecule/light- dependent modulation of cell activity and at tissue depths not currently achievable.